Transfer of Critical Reagent Products

For acquisition of critical reagents from the Defense Biological Product Assurance Office (DBPAO) that are required for basic research and product development activities supported by the NIAID.